Comparative Medicine Shared Resource

PROJECT SUMMARY: COMPARATIVE MEDICINE SHARED RESOURCE
The Comparative Medicine Shared Resource (CMSR) of the Fred Hutch/University of Washington/Seattle
Children’s Cancer Consortium provides high quality support for preclinical cancer research to Consortium
investigators. Under the direction of Gordon Roble, DVM, MBA, DACLAM, staff, including an additional 2.5
clinical and regulatory veterinarians and 1 veterinary pathologist, 2 staff scientists, 5 program managers, 12
veterinarian technicians/technical experts, and 27 husbandry personnel, provide expertise in laboratory animal
medicine and science, animal-use regulations, facility management, and daily care and treatment to six species
of animals currently housed at Fred Hutch (FH). CMSR maintains an AAALAC-accredited, USDA- registered,
and PHS-assured animal-use program located in 40,844 sf, and provides care for approximately 42,000 animals
daily, including mice, rats, fish, frogs, guinea pigs and hamsters. Researcher owned rodent housing is in two
centralized barrier facilities. By centralizing services, CMSR provides exceptional husbandry to maintain
microbiologic and environmental control of animal colonies. CMSR offers critical assets, including radioactive
and infectious agent containment housing and flexible space for specialized research needs such as reverse
light cycles or metabolic caging. Equipment support includes individually ventilated micro-isolator rodent cages,
a full-service rodent cage wash and autoclaves, and surgery-ready procedure rooms for rodent users. CMSR is
an invaluable resource enabling superior preclinical studies, starting with initial study consultation and planning
to ensure optimal research start-up time. This includes development and review of institutional animal care and
use committee protocols. A CMSR comparative pathologist provides diagnostic case review and rigorous
analysis of tissue samples from Consortium studies. The new Translational Research Model Services (TRMS)
arm of CMSR will incorporate the preclinical modeling shared resource (SR) team in the next renewal to deliver
rodent technical, surgical, breeding, and scientific support for research staff, including genetically engineered
and patient derived xenograft mouse models. CMSR offers extensive training opportunities for research staff in
general and specialized procedures, animal handling, and regulatory requirements. CMSR space also
accommodates the Consortium-supported Translational BioImaging Core SR, creating an environment for
significant inter-SR collaboration. One hundred sixty-five research groups depend on CMSR for success in
developing animal models of cancer and cancer-related disease states such as transplanted or induced liquid
and solid tumors, cancer-related pathogens, graft- versus-host disease, and conditions and treatments related
to radiation therapy. CMSR continues to expand the scope and volume of animal-related work, including the
proposed buildout and management of a high containment research facility (BSL-3/ABSL-3) to be located at FH,
allowing Consortium investigators to work with live virus for cellular and animal studies to enhance our ability to
work on molecular virology related to malignancy and design vaccines against virally mediated diseases.